TNFRSF13B polymorphisms and immunity to transplantation

Abstract:
The proposed research investigates how genomic polymorphism of the TNFRSF13B locus
predicts and potentially governs the character and outcome transplantation immunity in humans.
The investigators recently found (de Mattos Barbosa et al., 2021) non-synonymous mutations of
TNFRSF13B occur 5-fold more often in kidney transplant recipients that developed antibody-
mediated rejection than in recipients with persistently healthy grafts. Since TNFRSF13B
genotype determines production of natural antibodies, affinity-maturation, kinetics and
persistence of elicited antibody production, the genotype is hypothesized to determine whether
transplant immunity is dominated by bursts of high affinity pathogenic allospecific antibodies or
by steady state low affinity allo-specific antibodies with graft protective functions (mostly in
germline configurations). The proposed research will take advantage of access to a large pool of
DNA samples from recipients of kidney transplants at the Michigan Genomics Initiative
biorepository and those collected as part of the APOLLO study to connect genotypes with
transplantation outcomes. We will determine whether allelic TNFRSF13B variants of known
phenotype engender donor-specific B cell responses to organ allografts consistent with the
function of the variant studying recipients recruited at several major transplant centers. The
functional properties of the most important TNFRSF13B alleles will be confirmed and the
mechanism ascertained by engineered tnfrsf13B mutations in mice and testing such mice as
recipients of heterotopic cardiac allografts.

Public health relevance
The proposed research investigates how genomic polymorphisms of TNFRSF13B predict and potentially govern the character and outcome transplantation immunity in humans. We will determine whether allelic TNFRSF13B variants of known phenotype engender donor-specific B cell responses to organ allografts and the association of those responses with transplant outcome. The functional properties of the most important TNFRSF13B alleles will be confirmed and the mechanism ascertained by engineered tnfrsf13B mutations in mice and testing such mice as recipients of heterotopic cardiac allografts.